Program on Entrepreneurship and Innovation for Biomedical Product Development (EI4BPD)

Project Summary
Creating and maintaining a community of peers for SUD researchers is key to helping them
advance the inception of new products that deliver solutions for substance use disorders. To
ignite SUD researcher engagement via the online community tools, we must nurture a network
of human connections that exist between former and future program participants, industry
experts, speakers, coaches, and guests of the program to share research ideas and support
each other in the biomedical product development journey. Additional activities proposed to
nurture the Community of Peers continuously and effectively include outreach during the period
when the program is inactive (i.e. most of the year) and will include co-designing post-program
content to keep SUD researchers engaged with the curriculum, proactive previous cohort
involvement with the outreach, recruitment, curriculum delivery to the next cohorts, creation of
areas of focus around which cohorts can self-organize, and organization and on-going delivery
of live connections to top industry experts and peers with management and engineering
expertise. By facilitating a range of activities to curate the budding relationships in this
ecosystem, we create more opportunities for self-driven interactions. Empirical evidence for self-
driven interactions will be measured and fed back into the activities design for subsequent
years.

Public health relevance
Project Narrative Creating and maintaining a community of peers for SUD researchers is key to helping them advance the inception of new products that deliver effective solutions to address substance use disorders. This supplement aims to add ongoing interventions that will curate participation of peers from multiple cohorts, even when the program is not actively running, and will add industry experts to promote a self-driven community model. We will generate and track key metrics that quantify the emergence of self-driven interactions and their connection to curated activities